GARD SUPPORT SERVICES 2.0

Shared collaborative cloud environment, including cloud-based productivity tools, a service desk, commercial and open-source deployments of analytical tools for the Genetic and Rare Diseases Database.